Sexual dimorphic cell type and connectivity atlases of the aging and AD mouse brains

Project Abstract
In response to NOT-21-039 and related PAR-22-093, we propose this project to address several urgent needs
in the field. Mouse models spanning different ages and sexes are routinely used to quantify anatomic, molecular,
and pathologic changes in neurodegenerative diseases like Alzheimer’s Disease (AD). Yet, the only available
standard mouse brain atlases are constructed from 2-month-old adult male mice. Furthermore, although both
normal aging and AD neurodegeneration display sexually dimorphic features, the scientific community lacks the
sexually differentiated rodent brain atlases necessary to study these attributes. By applying cutting edge
technologies, we have developed for BRAIN Initiative connectomic and cell type mapping projects, we will (1)
generate sexually dimorphic 3D aging and AD brain atlases with granular hippocampus (HPF) molecular
domains, that can be used as standard atlas templates for all HPF work and (2) we will comprehensively
characterize morphological dystrophies, as well as connectional and synaptic disruptions, in aging and AD. In
Specific Aim 1, publicly available standard 3D HPF atlases of aging and AD brains will be created. Data will be
generated in 2-, 9-, and 18-month-old wildtype (WT), 5xFAD (early AD onset), and MAPT(H1)*N279K (late AD
onset) male and female mice. Fine HPF domain delineations will be facilitated by 3D volumetric images of cyto-
and myeloarchitecture, while additional histopathological markers (Aβ plaques/tau tangles) and
chemoarchitectural details (glutamate, GABA, PV, SST, Calb1) will be mapped to create comprehensive
histopathological and chemoarchitectural HPF atlases. In Specific Aim 2, We will systematically apply a genetic
MORF3 sparse labeling approach to label, reconstruct, and analyze cell type specific neuronal morphology of all
HPF regions at the granular level of their domains in WT, Vglut1.MORF3/5xFAD, PV.MORF3/5xFAD,
Vglut1.MORF3/MAPT(H1)*N279K, and PV.MORF3/MAPT(H1)*N279K mice across age and sex. Our whole
brain 3D clearing, immunostaining, imaging, and 3D neuronal reconstruction pipeline will be applied. Given that
an etiology of AD-related cognitive decline is selective HPF synaptic disruptions, with dorsal HPF nodes being
some of the earliest affected in AD, in Specific Aim 3, will examine progressive connectional disruptions along
amyloid and tau pathology progression. Male and female MORF3 and double transgenic mice, MORF3/5xFAD
and MORF3/MAPT(H1)*N279K, at 2m, 9m, and 18m of age will be used to reveal potential connectivity changes
across aging and AD. The same groups will be used to determine synaptic-level HPF disruptions with the
application of Expansion Microscopy that will capture super-resolution images of synaptic connections. In
Specific Aim 4, we will create a web-based data portal that enables visualization, comparison, and analysis of
neural circuits and cell types in 3D aging and AD brains. Our team, with decades of experience in connectomics,
brain atlasing, and online visualization, is sure to deliver standard HPF atlas templates for all neuroscience
research and to determine sexually dimorphic anatomic regions vulnerable across age and AD progression.

Public health relevance
Project Narrative Mouse models spanning different ages and sexes are routinely used to quantify anatomic, molecular, and pathologic changes in neurodegenerative diseases like Alzheimer’s Disease (AD), yet, the scientific community lacks sexually differentiated rodent brain atlases of different ages that are necessary to accurately study these attributes. By applying the most advanced technologies available, we will (1) generate publicly available, sexually dimorphic 3D hippocampal aging and AD brain atlases to be used as standard atlas templates for all aging and AD research and (2) we will comprehensively characterize morphological dystrophies, as well as connectional and synaptic disruptions, across aging and AD. Our team, with decades of experience in connectomics and brain atlasing, is sure to deliver standard hippocampal atlas templates for all neuroscience research and to determine sexually dimorphic anatomic regions vulnerable across age and AD progression.